Investigating the role of skin and gut microbiome in the onset of atopic dermatitis in infants

Project Summary/Abstract
Atopic dermatitis (AD) is a common chronic skin condition that affects over 10% of children in the US.
AD can significantly impact the quality of life by causing unbearable itching, leading to sleep loss and
infections. Unfortunately, there is currently no cure. The microbiome in both the skin and gut is
significantly altered in patients with AD. However, very few studies have investigated the role of
microbiome in the onset of AD in infants when AD symptoms usually appear. Moreover, little is known
about how the skin and gut microbiome interact with each other during the onset of AD, known as the
gut-skin axis. To fill this critical gap in our knowledge, Dr. Shen will utilize genomic, bioinformatic, and
experimental approaches to an unprecedentedly large pool of skin swabs, nasal swabs, and stool
samples from 608 infants, including 258 paired skin and stool samples, to facilitate the investigation
of the gut-skin axis. Dr. Shen will use ultra-deep shotgun metagenomic sequencing to capture
bacteria, fungi, and viruses in infants with AD at the species and strain level resolution. The
preliminary data have achieved high classification rates of metagenomic reads, and have indicated a
multi-kingdom decrease in skin microbial diversity and numerous differential gut microbial species
associated with AD. These data lead to a central hypothesis that the microbiome of both the skin and
gut plays an important role in the onset of AD in infants. This study aims to reveal full microbiome
signatures and the gut-skin microbiome relationships associated with the onset of AD. In Aim 1, Dr.
Shen will perform large-scale bioinformatic analyses to identify skin microbial taxa and genes
associated with the early onset of AD in infants, in the context of host genetics. Additionally, Dr. Shen
will experimentally test the effects of AD-associated microbes with neonatal wild-type mice. In Aim 2,
Dr. Shen will extend the computational approaches from Aim 1 to the gut metagenomic data and
integrate the skin and gut microbiome to reveal the gut-skin microbiome relationships in AD.
Furthermore, Dr. Shen will apply deep learning techniques to build the first microbiome-based
predictive model for AD outcomes, facilitating early prevention and intervention of the disease. The
proposed research and training plan will build on Dr. Shen’s strengths in the fields of bioinformatics
and microbiome, help him to develop necessary skills in experiments, and build his own professional
networks through conferences. Dr. Shen’s long-term goal is to extend the computational and
experimental techniques of this proposal to study the host-microbe interactions of the gut-skin axis in
AD. The unique environment of the NIH/NHGRI and the strong mentoring team of Dr. Shen will
enhance his research and career development, facilitating his transition to independence.

Public health relevance
Project Narrative Atopic dermatitis often begins in infancy and is accompanied by significant alterations in both the skin and gut microbiome. Understanding the roles and relationships of the skin and gut microbiome has the potential to inform novel therapeutic and preventive strategies for atopic dermatitis. The goal of the proposed studies is to utilize genomic, bioinformatic, and experimental approaches to fill this gap in our understanding of the role the microbiome plays in the initiation of atopic dermatitis.